Robust assays to define telomere maintenance mechanisms as cancer biomarkers.

Abstract
Telomeres are nucleoproteins with TTAGGG DNA repeats at the ends of chromosomes that protect coding DNA from
erosion and detection as DNA damage. Telomere maintenance is necessary for cancer cells to have unlimited proliferation
capacity. Most cancers maintain their telomeres via activation of the ribonucleoprotein telomerase containing a catalytic
subunit encoded by the TERT gene and an RNA template encoded by the TERC gene. Cancers with low or no telomerase
activity often use another mechanism to extend their telomeres, the Alternative Lengthening of Telomeres (ALT) in which
telomeres are maintained via homologous telomeric-DNA recombination, but the mechanism is still poorly understood.
ALT tumors contain extra-chromosomal telomeric DNA C-circles, which (detected with a unique PCR assay) provides a
specific and sensitive ALT biomarker. We have shown that quantifying TERT mRNA expression together with telomeric
DNA C-circles enables classifying cancers into 3 groups based on telomere maintenance mechanism (TMM); telomerase-
positive (high TERT), ALT-positive (C-circle+), and TMM-negative. Classifying the childhood cancer neuroblastoma by
TMM provides prognostic information that overrides currently employed clinical and biological prognostic markers, and
our preliminary data suggest this is possible for other cancer types. ALT cancers are consistently difficult to treat but have
dysfunctional telomeres, creating unique vulnerabilities that can provide novel therapeutic targets. For example, we have
recently demonstrated high ATM kinase activation at telomeres in ALT neuroblastoma leads to resistance to DNA damaging
chemotherapy that can be reversed with a clinical-stage ATM inhibitor AZD0156. Biomarkers of TMM provide both
prognostic information and the C-circle assay can potentially serve as a companion diagnostic assay to identify patients with
tumors that are likely to be more responsive to novel ALT-targeted therapies. Thus, it is important to define parameters
that impact accurate TMM assessment of cancers, i.e. accurate quantitation of TERT mRNA and DNA C-circles. We will
define the impact of collection and storage conditions and the minimum amounts of tissue and amounts, and quality of
nucleic acids needed for the assays. Identifying ALT patients from a blood sample would have clinical utility, and our
preliminary data suggest that C-circles can be detected in plasma containing circulating tumor DNA. Thus, we also propose
to develop and validate a plasma C-circle assay as a novel approach to identifying patients with ALT cancers. Finally, to
ensure that these assays can be used for clinical risk stratification, and as companion diagnostics for selection of therapy,
we propose to carry out studies necessary for CAP/CLIA certification of TERT mRNA qPCR and the telomeric DNA C-
circle assay. To accomplish our aims, we are integrating sample collection from adult and pediatric cancers together with
a team of experts in telomere biology and molecular pathology. This project will provide important information on analyzing
cancer TMM phenotype that will be of value to both research and clinical labs and will enable completion of regulatory
requirements necessary for clinical implementation of the assays.

Public health relevance
Project Narrative In order to continually grow, cancer cells need to maintain telomeres which if not maintained by some form of telomere maintenance mechanism (TMM) done by telomerase, an enzyme that adds telomeric repeats to the ends of chromosomes or by the alternative lengthening of telomeres (ALT) mechanism. This project will define parameters that impact on two assays needed to define cancer TMM as prognostic markers and companion diagnostics for novel drugs: TERT mRNA expression qPCR and the unique PCR assay for telomeric DNA C-circles, which provides a specific marker for ALT cancers. We will also develop an assay to detect C-circles in patient blood samples and complete regulatory steps needed for clinical implementation of these assays.